Biotyping Mood Health in Late Adolescence: Neurocognitive Dimensions and Stress Pathways

Project Summary
Adolescence is a developmental period marked by interconnected changes in cognitive and neurobiological
functioning, including reorganization of large-scale functional networks and improved ability to regulate attention
and pursue rewards. Adolescence is also a period characterized by heightened stress and increased symptoms
of mood disorders (MD), which are in turn associated with neurocognitive abnormalities in the same brain
networks and cognitive domains that are highly plastic in adolescence. These developmental convergences
suggest a model in which abnormalities in key neurocognitive dimensions predispose teens to MD, possibly
because neurocognitive impairment impedes healthy stress coping behavior. However, shared risk factors and
similarities in early-stage symptomatology of various MD have made it challenging to determine the specific
pathways by which neurocognitive abnormalities contribute to MD. The proposed study will address these
challenges with a multi-modal, longitudinal evaluation of risk “biotypes”, stress responses, and MD symptoms in
adolescence. We will recruit a sample of n=144 adolescents ages 14-19 (n=96 at high familial risk of MD) to
participate in a 24-month study consisting of neuroimaging, cognitive testing, and symptom assessment (at
baseline and 12 months), and mobile-app/telephone follow-up evaluations (once per 6 months) of stress
events/responses and symptoms. We will apply latent variable analysis to behavioral and neuroimaging
measures to evaluate individual differences in key neurocognitive dimensions related to: (1) cognitive regulation
(CR), and (2) reward sensitivity (RS). Multilevel models will test the effects of CR and RS on future mood
symptoms as mediated by stress-reactive behaviors. We aim to first use biotypes defined by abnormalities in
these neurocognitive dimensions to predict stress-reactive behavior and mood symptoms over a two-year follow-
up (Aim 1), and to second, provide a more precise understanding of neurocognitive subdimensions – focusing
on RS subdimensions - that best carve the mood symptom space (Aim 2). In addition, in order to explore
temporal characteristics of biotypes, we will test the stability of RS over time (Exploratory Aim 1) and to explore
moderators of biotype expression, we will test the effects of biological sex and age (Exploratory Aim 2).
Ultimately, this work may be a crucial step towards the translational goal of using neurocognitive biotypes to
differentially diagnose and predict MD.

Public health relevance
Project Narrative Adolescence is a developmental period characterized by significant gains in cognitive regulation and motivated behavior – but also, heightened vulnerability to mood pathology that is difficult to predict in individual teens. The proposed study takes a multi-modal, longitudinal approach to understand how abnormalities in key dimensions of neurocognitive functioning produce risk biotypes that contribute to specific maladaptive behaviors and mood symptoms in adolescence. This research has the goal of informing translational research that uses biotyping to differentially diagnose and forecast psychopathology on a personalized, patient-specific basis.